Task Order 11- Nonclinical Toxicology Study of an investigational agent in development for anticancer therapy

Test agents are being considered for development as an anticancer therapeutics. To generate information to identify drugs with the potential to treat cancer, maintenance of test systems for a defined period of time was required.